Cell therapy regulates cardiac healing through innate immune response

Abstract
Myocardial infarction (MI) due to underlying atherosclerosis is the leading disease
sequela that precipitates heart failure in the Western world. Our ability to treat these
patients and their heart failure has not progressed beyond a mild 20-30% extension in
life span realized some 3 decades ago with neuroendocrine-based management. New
therapeutic avenues are needed, the most dramatic of which would be directly
generating new cardiomyocyte to regenerate the damaged area of heart tissue.
Previous attempts to regenerate the heart through new myocyte production have not
been successful despite more than 15 years of research using adult progenitor cells.
However, studies with cardiac progenitor cells in rodent models did show a functional
benefit to the MI-injured heart, and we and others have identified a novel mechanism of
benefit whereby cell therapy has a rejuvenating effect through refinement of the immune
response. Indeed, we have shown that cell therapy injections can optimize healing,
reduce infarct area expansion and augment scar borderzone physical properties
(Vagnozzi et al., 2020, Nature). These beneficial effects were mediated through
selective macrophage subtype activity in the heart, underscoring the importance of the
immune response in infarct healing and compensation. Here we propose the hypothesis
that selective innate immune response signaling pathways, and macrophage subtype
polarization can be exploited to further heal MI injury and to explain how cell therapy
functions in vivo. Our more specific hypothesis is that MI injury or cell therapy has an
underlying protective component through cGAS-Sting in both cardiomyocytes and
macrophages, and this can be therapeutically exploited to polarize the immune response
for better healing. The specific aims are: AIM #1, To use mouse genetics to identify the
specific immune cell-types in the heart that mediate cell therapy-based cardiac
rejuvenation post-MI injury. AIM #2, To examine the mechanism of innate immune
signaling in the heart through cGAS-Sting. AIM #3, To investigate the mechanisms
whereby cell therapy rejuvenates the post-MI injured heart. Such studies will be critical
for examining how innate immune signaling at the level of macrophages impacts the
heart during an inflammatory injury response or due to cell therapy with the goal of
modifying this response to benefit healing in patients.

Public health relevance
Relevance The relevance of this application is rooted in the fundamental translational biology of how the immune system impacts cardiac disease presentation and resolution. It is very important to understand and define the basic science mechanisms underlying how the adult human heart heals after ischemic injury and how the immune system intimately regulates this process. Here we will attempt to define therapeutic applications for directly altering the immune response in the heart during and after injury.